Project 3: Mitochondrial and cellular mechanisms of neurotoxicity of Superfund chemical co-exposures

Abstract
In ongoing work by this Project, we have found that developmental exposures to mitochondrial toxicants cause
neurotoxic outcomes in Caenorhabditis elegans, including morphological alterations in neurons, altered
behavior, and, in the long term, increased susceptibility to neurodegeneration. In line with the EPA, we describe
all of these as “developmental neurotoxicity (DNT),” because they result from exposures that occur during
development. Two important and overarching mechanisms of DNT are 1) changes to neurogenesis resulting in
altered cell fate, morphology, and connectivity (“hardwiring”), and 2) persistent changes to the function of
neurons that appear to be morphologically normal (epigenetic “programming”). Distinguishing these is
challenging; we propose a novel and powerful way to assess each possibility. We will begin with an in vivo yet
relatively high-throughput and economic model, C. elegans. C. elegans offers an additional, key benefit:
developmental neurogenesis is normally invariant, permitting clear identification of variation in hardwiring as well
as behavioral and stress-responsive changes without morphological alteration (programming). Work in C.
elegans will be followed by testing in human neuronal stem cells (hNSCs) that permit human-relevant DNT
testing, plus the opportunity to identify sex-specific differences and epigenetic modifications.
Relatively few chemicals have been rigorously evaluated for DNT. The paucity of information is even more
pronounced for chemical co-exposures, despite the fact that combined exposures are the reality. This lack of
testing of mixtures results partly from regulatory policy, and partly from technical challenges in laboratory testing
of co-exposures. Our combined in vivo-in vitro approach will permit us to rigorously test for DNT resulting from
both complex environmental mixtures, and from defined combinations of individual Superfund chemicals that we
will evaluate for non-additive effects. We will test the effects of the prototypical developmental neurotoxicants
Pb, Cd, and polycyclic aromatic hydrocarbons, singly and in combinations dictated by known environmental
concentrations. We will compare our outcomes in C. elegans and hNSCs, to those obtained by other Projects in
fish, rats, and people. Demonstration that C. elegans can be reliably used to investigate mixture DNT will add a
powerful new model for testing and regulation of environmental mixtures.
Finally, we will test the degree to which mitochondrial dysfunction, key to neurodevelopment, drives DNT by
these prototypical chemicals. These chemicals have multiple molecular targets, including but not limited to
different mitochondrial macromolecules. The fact that these chemicals individually all affect mitochondria and
neurons, but by different mechanisms, is why we predict synergistic interactions. However, while mitochondria
are known targets of these chemicals, the extent to which mitochondrial toxicity drives their DNT is not known.
Our work will establish the contribution of mitochondrial dysfunction in single and combined chemical DNT,
informing development of adverse outcome pathways and intervention efforts.

Public health relevance
Project Narrative Exposure of the developing nervous system to environmental contaminants can have life-long effects, as illustrated by a few well-known examples such as lead. The degree to which combined exposures to multiple chemicals can adversely impact neurodevelopment is very poorly understood, although people are invariably exposed to mixtures, not single compounds. We will test the developmental neurotoxicity of combined exposures to common and important pollutants in order to provide information and a new cost- and time- efficient tool that could be used with real-life complex mixtures to test whether current regulatory actions at Superfund sites are adequate for protecting against adverse impacts on the developing nervous system.